Machine Learning and Deformable Model-based 4D Characterization of Cardiac Dyssynchrony from MRI

Summary/Abstract
In the presence of diseases such as ischemic heart disease (IHD), cardiac dyssynchrony deteriorates cardiac
function and often cannot be treated effectively. However, while imaging methods such as cardiovascular
magnetic resonance (CMR) can provide high quality images of the moving heart, conventional clinical
quantitative analysis of cardiac function is largely limited to global function analysis of the left ventricle (LV),
with only qualitative and subjective characterization of regional function. An obstacle to better quantification of
regional function is the complex 3D structure and motion of the heart wall, which has typically necessitated
time-consuming user-guided processing of the images to carry out the associated 3D-motion analysis.
Recent advances in machine-learning (ML) approaches for image analysis are promising as new means to
speed up the processing of cardiac images, as well as to analyze the underlying regional motion patterns.
However, current Deep ML (DML) approaches to image analysis largely function as “black boxes”, without
clear indications of which features contribute most to the analysis results, thus limiting their clinical utility. In
the initial funded period of this research project, we have been developing integrated approaches to the
segmentation, 3D reconstruction, and analysis of CMR data, with application to the evaluation of cardiac
dyssynchrony. Today, treatment of dyssynchrony in HF with cardiac resynchronization therapy (CRT) leads to
improvement in only ~2/3 patients selected with conventional criteria (usually by electrocardiogram [ECG]).
Our initial results show encouraging results of correlation between MRI evaluation of dyssynchrony and
cardiac resynchronization therapy (CRT) outcomes. In the new proposed research, we will further develop
these methods, with the goal of automating the cardiac analysis methods. This will include the introduction of
new ML-based methods, which will incorporate information on the specific cardiac motion factors that lead to
classification of different disease states in dyssynchrony. Our Hypothesis is that by using these new ML-based
methods for cardiac motion analysis, we will discover and evaluate significant quantitative correlations
between different cardiac dyssynchrony motion patterns and CRT outcomes. Also, late-gadolinium
enhancement (LGE) provides images for infarction visualization. Incorporation of tissue characterization into
the motion-pattern analysis could lead to increased understanding of how infarcted areas affect regional
motion in concert with dyssynchrony. The unearthing of these findings will allow us to validate them in future
clinical studies.
The project will also disseminate our novel, coupled DML and model-based methodology for quantifying and
classifying cardiac motion in diseases affecting regional wall motion. Other research groups can then apply our
tools to specifically study dyssynchrony, as well as other cardiac diseases affecting LV motion.

Public health relevance
Project Narrative A significant proportion of patients with heart failure and cardiac dyssynchrony fail to positively respond to cardiac resynchronization therapy (CRT), as the current clinical selection criteria do not take into account regional cardiac function. We will develop improved methods for 4D-analysis and -visualization of both global and regional cardiac function from cardiovascular magnetic resonance (CMR) data, including novel deep learning methods that will provide additional information on the salient features that contribute most to characterization of cardiac dyssynchrony. These new methods will be applied to the analysis of CMR data from both a stratified sample of normal subjects and patients with cardiac dyssynchrony (with and without infarction), with correlation with therapeutic results following CRT, potentially leading to improved clinical guidelines and clinical outcomes, as well as increased understanding of cardiac physiology and pathophysiology.